Exercising language: Behavioral and neurophysiological changes after high-intensity exercise training in post-stroke aphasia

Project Summary/Abstract
Losing the ability to speak and understand language is devastating for patients with aphasia and their
families, negatively impacting multiple aspects of life and emotional well-being. Unfortunately, individuals with
aphasia rarely regain their language skills in full. Novel approaches are required that boost the effects of
traditional therapies, leading to better outcomes for people with aphasia. The proposed study seeks to evaluate
the effects of a promising adjuvant intervention – high-intensity physical exercise training - on recovery in
aphasia. A new exercise program, specifically designed for individuals with post-stroke motor and language
deficits and with documented safety, feasibility and fidelity in this clinical population, will be the means of
providing a safe, stroke- and aphasia-friendly high-intensity exercise intervention to achieve optimal physical
and behavioral gains. Innovative outcome measures will include not only language and cognitive measures but
also measures of motor skills and psychological and psychosocial outcomes that will holistically assess the
benefits of physical exercise. Another cutting-edge aspect of the study is the inclusion of advanced physiological
fitness measures and neuroimaging metrics of blood flow and cerebrovascular reactivity as outcome measures,
to afford a deeper understanding of the exercise-mediated behavioral and neural effects in stroke survivors.
We will recruit 110 individuals with aphasia to evaluate the multi-faceted impact of high-intensity exercise
on outcomes and compare its effects to an active control condition involving standard-of-care low-intensity
exercise. Participants will be randomly assigned to one of the two conditions. The overall format of the control
intervention will be very similar to the target intervention, i.e., it will offer the same level of social and activity
benefits but without the cardiovascular demands and strengthening components of the high intensity target
condition. This will allow us to precisely isolate the key ingredients behind expected exercise-induced changes in
language and cognition and definitively test whether the high-intensity aspect of the exercise – the premise of
this project – leads to behavioral gains. First, the benefits of high-intensity exercise for language, cognition,
motor, and emotional and psychological well-being in individuals with aphasia will be established. Second, it will
be determined how exercise-induced changes in physical fitness are related to changes in language and cognitive
measures. Third, to advance our knowledge about the brain mechanisms of the observed cognitive and language
benefits, exercise-induced neurovascular changes that relate to behavioral improvements will be carefully
evaluated. The validated physical exercise intervention resulting from this project will offer a new tool to
clinicians seeking to help individuals with aphasia, either as a free-standing program to enhance physical health,
cognition, and well-being, or as a supplementary therapy to standard speech-language therapy. Ultimately, this
work could significantly alter our thinking about ancillary aphasia therapies that can benefit those with stroke
and aphasia through non-traditional means, in this case, a promising, safe, cost-efficient adjunct intervention.

Public health relevance
Project Narrative More than two million people in the U.S. alone suffer from aphasia, a neurogenic language disorder usually caused by stroke or other neurologic disease. Traditional speech-language therapy is certainly helpful, but individuals with aphasia rarely regain their language skills in full. The proposed study seeks to evaluate the effects of high-intensity physical exercise, a very promising, but surprisingly overlooked adjuvant intervention, on language and cognitive performance, as well as general and brain health, emotional and psychosocial outcomes in a large group of stroke survivors with aphasia.